PHARMACOKINETICS OF SODIUM BOROCAPTATE IN ANAPLASTIC ASTROCYTOMA

This protocol aims to carry out a comprehensive study on the pharmacokinetics and biodistribution of BSH, a boron compound at that time that has been used as a capture agent in Boron Neutron Capture Theory (BNCT), a type of radiation therapy, in patients with brain tumors and for which there are reported claims of therapeutic efficacy.